A new molecular therapy against ocular herpes

Herpes simplex virus type-1 (HSV-1) is a herpesvirus known to cause long-term morbidities in the eye and
serious vision problems. In our previously funded period, we discovered the high efficacy, unique mode of action,
pharmacokinetics, safety, and superior antiviral properties of BX795 against HSV-1 in the eye. Our findings
provided a new understanding of host protein targets involved in HSV-1 infection of the cornea. Through
extensive transcriptomic and proteomic analyses of BX795, we uncovered a novel cell cycle regulatory mode of
action with broader scientific implications beyond its antiviral properties. Due to our extensive studies, BX795
shows strong promise as a new topical antiviral for ocular herpes, and it can now be pursued for Phase 1 clinical
studies. However, our studies also revealed an interesting challenge: BX795 failed to synergistically enhance
other clinically relevant drugs, specifically nucleoside analogs like ACV and TFT, commonly used for ocular HSV-
1 infections. To address the scientific curiosity about whether a functional analog of BX795 can exhibit synergism
with existing antivirals, we utilized our omics data, conducted in silico L1000 assay-based CMap predictions, and
identified another small molecule, GW8150, as the closest functional analog of BX795. Our preliminary data
demonstrated high efficacy, low toxicity, and, to our satisfaction, strong synergy with ACV and TFT. Thus,
GW8150 presents a valuable new tool to study the pathways contributing to HSV-1 infection in the eye,
understand why synergy was absent in BX795, and offer a potential candidate for topical or oral antiviral
development. To achieve our goals, we have defined three specific aims for the competitive renewal period: first,
to determine GW8510's antiviral action and its impact on corneal cells by analyzing Omics data and identifying
interactions with corneal cell proteins and changes in cell proteomes; second, to assess the therapeutic benefits
of topically delivered GW8510 in murine models of ocular HSV-1 infection, establishing it as a potent candidate
for further development as an FDA approved antiviral for ocular indications; and third, to investigate GW8510's
synergistic abilities in reducing ocular HSV-1 infection, potentially in combination with clinically approved drugs,
with the aim of enhancing antiviral efficacy, improving treatment options, and exploiting transcriptomics and
proteomics analyses to uncover the specific targets and pathways that underpin this synergistic antiviral action.
Post-treatment corneal, as well as retinal health and associated vision functions, will be examined to determine
the benefits (and/or any toxic effects) of drug administration. By completing these specific aims, we aim to gain
valuable insights into ocular antiviral mechanisms, new proviral pathways targeted by GW8510, and develop
more effective strategies to combat HSV-1 infections in the eye. This research holds promise for advancing our
understanding and treatment of ocular herpes, improving patient outcomes, and contributing to the development
of novel ocular antiviral therapies.

Public health relevance
This proposal identifies GW8510 as a new and functionally improved analog of BX795, which inhibits ocular herpes infection. This small molecule can strongly inhibit as well as synergistically enhance the efficacy of clinical antivirals. We will use GW8510 to study proviral mechanisms in the cornea and improve our understanding of its safety and efficacy in murine eyes using lab and clinical strains of ocular HSV-1.